Functional Role of Tetraspanin CD82 in Hematopoietic Stem Cell Interactions

PROJECT SUMMARY
The significant cellular demand of the hematopoietic system is maintained by a rare pool of tissue-specific,
hematopoietic stem and progenitor cells (HSPCs) that are primarily found in a quiescent state. Upon
hematopoietic stresses, such as significant bleeding, overwhelming infection, radiation exposure and
myelosuppressive therapy, HSPCs are rapidly recruited into cell cycle, but ultimately must return to
quiescence. The ability to transiently modulate HSPC return to quiescence has the potential to extend the
activation of HSPCs and significantly improve overall patient outcomes from hematopoietic stresses and for
transplantation therapies. However, in order to leverage a transient extension of HSPC activation to improve
the regenerative response to stress, we must first understand the mechanisms by which the complex network
of cell-intrinsic and -extrinsic signaling within the bone marrow are coupled to regulate HSPC quiescence. The
objective of our current proposal is to evaluate the tetraspanin membrane-scaffold protein, CD82, as a
tractable target to modulate HSPC quiescence signaling within the bone marrow. Tetraspanins are a family of
membrane-scaffold proteins with the unique ability to regulate cell-cell/cell-matrix interactions and modulate
intracellular signaling, thus linking cell-microenvironment interactions to downstream signaling consequences.
Our new preliminary data indicate that the CD82 scaffold promotes a quiescent HSPC phenotype when cells
are niche engaged and implicate a role for Transforming Growth Factor  (TGF) signaling. Thus, in this
proposal, we will test the hypothesis that the CD82 membrane scaffold promotes HSPC quiescence by
organizing and enhancing the signaling activity of a TGF receptor complex within the bone marrow niche. In
Specific Aim 1, we will determine the molecular mechanisms by which CD82 modulates the TGFβ signaling
response of HSPCs. For Specific Aim 2, we will identify the mechanism by which CD82 promotes the spatial
activation of TGF signaling locally within the bone marrow niche during hematopoietic stress. In Specific Aim
3, we will evaluate CD82 as a therapeutic target to improve the hematopoietic regeneration response to
hematologic injury. In pursuit of these aims, we will apply an innovative combinatorial approach that includes
mutational analysis, biochemistry and sophisticated imaging techniques, which will enable us to obtain a multi-
scale understanding of the mechanisms by which CD82 regulates TGF signal transduction in the context of
hematopoietic stress. Moreover, the successful completion of the proposed aims will be significant because we
expect to integrate mechanistic insights across multiple scales to identify the multifaceted contribution of CD82
to the regulation of TGF signaling in the context of hematopoietic stress and quiescence, which will build a
foundation for the development of improved therapeutics that locally target the complex TGF signaling
cascade within the bone marrow.

Public health relevance
PROJECT NARRATIVE Recovery from hematopoietic injuries, which include significant bleeding, overwhelming infection, radiation exposure and myelosuppressive therapy, will benefit from strategies that modulate hematopoietic stem cell activation and return to quiescence. The proposed research contributes to human health by increasing the understanding of the molecular and cellular mechanisms responsible for the tight regulation of hematopoietic stem cell quiescence signaling within the bone marrow. Knowledge of the basic mechanisms that regulate hematopoietic stem cell quiescence within the bone marrow will aid in the identification of therapeutic targets that improve the regeneration response to hematologic injury, significantly improving overall patient outcomes from hematopoietic stresses.